Harnessing the innate immunotransmitter cGAMP for anti-cancer therapy

PROJECT SUMMARY/ABSTRACT No change from original proposed activities.

Public health relevance
PROJECT NARRATIVE No change from original proposed activities.